COMPUTER ASSISTED NIMH DIAGNOSTIC INTERVIEW SCHEDULE

The purpose of the contract is to produce and distribute the generic and Windows C-DISC to DHHS funded research studies for a reasonable license fee plus the cost of production, manuals, updating, and technical support. In addition, the contractor shall undertake further development of the C-DISC and assure that modified or derivative versions meet the specification of the NIMH DISC Editorial Board and have the explicit concurrence of the NIMH GPO. The contractor shall provide NIMH with a license to use the C-DISC and the programming source code tools on which it was developed for the benefit of DHHS funded investigators.